Development of a Virtual Preclinical CT Platform for Advanced Imaging and Theranostics in Head and Neck Cancer Research

Abstract
Effective treatment of aggressive and treatment-resistant cancers, such as head and neck squamous cell
carcinoma (HNSCC), demands innovative methodologies that accurately capture the complexities of the tumor
microenvironment and predict therapeutic responses. However, traditional imaging techniques alone may not
fully capture the complex and dynamic processes of tumor growth, angiogenesis, and therapeutic responses,
limiting our ability to develop and optimize effective treatments. This project aims to develop a Virtual
Preclinical CT (VPCT) platform to serve as a "digital twin" for studying preclinical cancer models of HNSCC. By
integrating advanced photon-counting CT (PCCT) imaging with sophisticated computational models, the VPCT
platform will simulate tumor behavior, optimize imaging protocols, and evaluate therapeutic interventions in a
virtual setting. The VPCT platform will combine high-resolution tumor and vascular models with PCCT
simulations to accurately replicate the anatomical and physiological complexity of mouse cancer models,
thereby enabling precise simulations of therapeutic outcomes. Our approach is organized into three specific
aims: Aim 1 focuses on developing the VPCT imaging platform by enhancing digital mouse phantoms with
detailed vascular and tumor models derived from high-resolution PCCT data and integrating multiscale tumor
models using computational platforms like CompuCell3D. Aim 2 will validate the VPCT platform by comparing
simulated imaging data with empirical data from custom-designed phantoms and in vivo PCCT imaging of
HNSCC tumors, ensuring the platform’s accuracy in material separation and vascular mapping. Aim 3 will
leverage the validated VPCT platform to optimize and evaluate radiation therapy (RT) and combination
treatments for HNSCC. Specifically, we will identify the optimal timing for injecting high atomic number (Z)
barium nanoparticles (VivoVist™) in relation to RT to maximize vascular disruption and enhance the enhanced
permeability and retention (EPR) effect. Additionally, we will explore the synergistic potential of combining
VivoVist™ nanoparticles with RT and the chemotherapy agent Doxil (liposomal doxorubicin). By integrating
advanced radiomics, machine learning, and computational pathology, we aim to understand therapeutic
strategies and significantly improve the accuracy of treatment outcome predictions. The VPCT platform is
anticipated to significantly improve tumor modeling and optimize PCCT protocols for assessing the effects of
RT on tumor vasculature and evaluating combination therapies. By focusing on vascular changes and the
synergistic effects of combined treatments, the platform will offer critical insights for refining RT and
chemotherapeutic strategies in cancer treatment. Additionally, integrating advanced computational techniques
will enhance predictive accuracy, enabling preclinical findings to directly inform clinical applications and
advance personalized cancer therapies.

Public health relevance
PROJECT NARRATIVE: This project aims to create a virtual imaging platform that mimics cancer growth and treatment responses, specifically for aggressive cancers like head and neck tumors. By combining advanced computer models with cutting-edge CT imaging, this platform will help researchers better understand how tumors develop and respond to therapies. Ultimately, the findings from this project could lead to more personalized and effective treatment strategies for cancer patients.